Targeting Membrane Environments: The Role of Oleate Hydratase (OhyA) in Lipid-Protein Interactions Across Microbial Communities

PROJECT SUMMARY/ABSTRACT
Membrane integrity and function in biological systems heavily rely on lipid-protein interactions, particularly the
role of proteins in concentrating signaling molecules within cellular membranes. Oleate hydratase (OhyA) is a
microbial enzyme crucial in modifying unsaturated fatty acids (UFA) within cell membranes, transforming them
into anti-inflammatory hydroxy fatty acids (hFA). This enzymatic activity is pivotal for various physiological
processes, including gut health maintenance and immune response modulation. Despite its importance, the
molecular mechanisms underpinning OhyA's membrane interaction and catalytic function, especially in
pathogenic and commensal bacteria, remain unclear.
Our research aims to elucidate the fundamental aspects of OhyA biology, focusing on three areas: investigation
of how OhyA acquires UFA substrates from the membrane, understanding how bacteria utilize OhyA and
distribute hFA to support colonization and immune modulation, and exploring the catalytic mechanisms of OhyA
variants lacking typical functional domains. Our multidisciplinary approach leverages advanced structural
biology, lipidomics, and genetic techniques to uncover novel insights into microbial physiology and protein-
membrane interactions. This innovative framework promises significant contributions to both fundamental
science and applied biotechnology.
Characterizing OhyA and its role in lipid metabolism and immune modulation is pivotal for understanding
bacterial pathogenesis and commensalism. Insights gained will inform biotechnological advancements,
potentially facilitating the development of novel therapeutic strategies targeting microbial lipid metabolism.
Our recent advances include solving crystal structures of OhyA•liposome complexes and identifying membrane-
targeting domains, developing robust lipidomics pipelines for hFA quantification in biological samples, and
establishing PPAR alpha as a key target for immunomodulatory hFA signaling. Our future investigations will
expand on these foundations: defining the ecological relevance of OhyA in intestinal microbiomes using diverse
murine models, determining the molecular details of OhyA-membrane interactions across bacterial taxa, and
elucidating catalytic mechanisms of unusual OhyA variants and their implications for enzyme engineering.
In summary, our research program aims to advance understanding of OhyA-mediated lipid metabolism in
microbial communities, paving the way for innovations in microbiome science and biotechnological applications.

Public health relevance
PROJECT NARRATIVE The research on oleate hydratase (OhyA) promises significant contributions to our understanding of bacterial physiology and human health applications. By elucidating how OhyA interacts with bacterial membranes to access and modify fatty acids, this study addresses fundamental questions about protein targeting and enzymatic function in host lipid-rich environments. This knowledge will enhance our grasp of microbial ecology and host-microbe interactions within diverse anatomical sites, and also holds the potential for developing novel biocatalysts and therapeutic strategies aimed at modulating inflammation and metabolic disorders through targeted lipid interventions.